Role of CEBP transcription factors in regulating cell gr

Cancers arise when cells escape normal controls on proliferation through activation of oncogenes and also bypass fail-safe barriers imposed by tumor suppressors that normally cause apoptosis or growth arrest (senescence) of pre-malignant cells. Proto-oncogenes encoding Ras GTPases are frequently activated in cancer cells, while components of the p53 or RB tumor suppressor pathways are disrupted in nearly all tumors. Elucidating the fundamental components of these oncogenic and anti-oncogenic pathways is essential for understanding how cancers develop and to identify unique vulnerabilities of tumor cells that can be exploited for therapeutic advantage. Our laboratory studies the C/EBP (CCAAT/enhancer binding protein) family of bZIP transcription factors, with particular emphasis on their involvement in cell proliferation and tumorigenesis. Our current research focuses on the functions and regulation of C/EBPbeta as a downstream effector of Ras and its role in tumor cells. Recent work from our laboratory also implicates C/EBPbeta in oncogene-induced senescence of primary fibroblasts, where it acts to restrain proliferation of cells expressing activated Ras by a mechanism requiring RB:E2F. C/EBPbeta may therefore possess both pro- and anti-tumorigenic properties. We seek to understand these opposing functions of C/EBPbeta in more mechanistic detail and to illuminate their contributions to cancer development in vivo.Post-translational regulation of C/EBPbeta activity: The DNA-binding activity of C/EBPbeta is intrinsically repressed and is activated in cells expressing oncogenic Ras or stimulated with growth factors. C/EBPbeta auto-inhibition requires at least three regions in the N-terminal half of the protein that are predicted to form secondary structure. We have mapped Ras-induced sites of phosphorylation on C/EBPbeta and identified a RSK kinase site in the leucine zipper as an important regulator of C/EBPbeta DNA-binding activity and dimerization. We are continuing to investigate how phosphorylation and other modifications such as lysine acetylation control C/EBPbeta DNA-binding, dimerization, and transcriptional activity and how such modifications affect its biological and oncogenic properties.C/EBPbeta and tumorigenesis: Work from our laboratory and others has revealed a critical role for C/EBPbeta in the development of certain cancers. C/EBPbeta-deficient mice were shown to be completely resistant to skin tumors induced by carcinogens that cause Ras mutations. C/EBPbeta is also essential for Myc/Raf-induced transformation of monocyte/macrophages and is required for these cells to evade apoptosis in the absence of extrinsic growth factors, a hallmark of leukemias and other tumor cells. We identified the IGF-I gene as a transcriptional target of C/EBPbeta in transformed macrophages and demonstrated that the survival defect of C/EBPbeta null cells stems from impaired autocrine signaling by IGF-I. To determine whether C/EBPbeta affects other kinds of tumors, we are investigating the effect of C/EBPbeta deficiency on carcinogen-induced cancers. Preliminary results indicate that C/EBPbeta KO mice exposed to ENU fail to develop lymphomas and show reduced incidence or malignancy of many other cancers. To extend these findings we are currently intercrossing C/EBPbeta KO mice with transgenic strains that develop tumors in specific tissues. We are also examining the expression and function of C/EBPbeta in human tumor cell lines to extend our findings to human malignancies.Role of C/EBPbeta in cellular senescence: In many primary (non-immortalized) cells, elevated levels of activated Ras or other oncogenes induce senescence, a stable form of cell cycle arrest that requires induction of the ARF-p53 and p16Ink4a-RB tumor suppressor pathways. Recent work indicates that oncogene-induced senescence (OIS) serves as a tumor surveillance mechanism in vivo.